Development of antifungal drug resistance in the oral environment over the course of HIV infection

Fungal infections are an increasing human health risk, and the development of fungal resistance to the
limited repertoire of available drugs is exacerbating this threat. Five species within the genus Candida
predominantly cause disease manifestations in humans, especially in immunocompromised individuals.
Indeed, candidiasis is the most common opportunistic oral infection affecting people with AIDS. Earlier work by
our group and others demonstrated changes in oral fungal composition and mutational changes in
antimicrobial resistance (AMR) genes throughout the course of HIV infection and treatment, suggesting a
uniqueness to the oral environment. Although there are several known molecular mechanisms that confer
antifungal resistance, recent studies suggest the high likelihood that there are many novel mechanisms yet to
be identified. Our goals are to employ evolutionary genomic approaches to gain both basic and applied insights
on the oral environment that will inform diagnostics and ultimately treatment. Our central hypothesis is that
fungi will evolve over time in the oral environment, and this R03 is designed to demonstrate both support for
this hypothesis and feasibility of the novel methods we are developing. Our proposed work leverages an earlier
case-control study (“Crosstalk”) by one of our team members and includes a set of 50 HIV-positive and HAART
naïve individuals, and 76 HIV-negative controls, over a 5-year study period. Deidentified and cryopreserved
saliva, caries swabs, fungal cultures, and bacterial cultures from these patients are immediately available,
along with associated clinical and demographic data.
In Aim 1 we will use direct long-read sequencing on patient saliva and caries swabs to determine the
fungal mycobiome at unprecedented resolution. This profiling will come from direct sequence analysis of the
full-length Candida rRNA operon from patient samples.
In Aim 2 we will determine the fungal resistome of the same samples over the course of treatment. We
will perform longitudinal profiling by hybridization-capture with biotinylated probes to target known fungal AMR
and biofilm-associated genes. These genes will then be analyzed for SNPs over time and for signatures of
positive selection pressure.
We will next propose an R01 with a goal of identifying new fungal genetic AMR determinants using
pan-genomic and molecular adaptation analyses on fungal cultures from Crosstalk and more recent isolates.
This takes advantage of the recent discovery that fungi, like bacteria, have a core and an accessory genome;
we plan to correlate the genes from the accessory genome, and SNPs across the genome, with AMR
phenotype data, concentrating on Candida species common to the HIV oral environment. We expect that this
project will identify putative novel Candida antifungal resistance mechanisms and provide much needed
information on Candida evolution in the oral environment.

Public health relevance
Fungal drug resistance is an emerging threat to public health and especially immunocompromised individuals. The proposed research will examine fungal species and their genes driving resistance in the oral environment of HIV patients with a long-term goal of improved diagnostics to optimize treatment. The project is relevant to the NIH mission in its combination of fundamental biological research on molecular mechanisms of drug resistance with application to enhance human health.